Advancing Equity in Rare Disease Genomics

Project Summary
Genomic research presents a unique opportunity for molecular diagnosis of individuals with rare disease, which
may empower precision therapies to alleviate the individual and public health burden of these conditions.
However, minoritized populations remain underrepresented in rare disease genomic research, and optimal
strategies to address this lack of representation remain poorly understood. The consequences of these
knowledge gaps extend beyond the research realm and threaten the equitable provision of genomic medicine
services in clinical practice. This project takes the critical next step towards further understanding, and ultimately
breaking down, barriers to rare disease genomic research participation for historically underrepresented
populations, in a hybrid type 3 effectiveness-implementation study design informed by the RE-AIM (Reach,
Effectiveness, Adoption, Implementation, Maintenance) framework. A diversity, equity, and inclusion toolkit for
genomic researchers will be developed and implemented within the Broad Institute’s Rare Genomes Project
(Aim 1), with concurrent evaluation of multiple dimensions of effectiveness employing a mixed-methods
approach (Aims 2 and 3). In Aim 1, stakeholder interviews will be conducted with both rare disease genomic
research participants as well as providers who refer these participants to further explore barriers and facilitators
of research engagement, with specific attention to study logistics and inclusive practices. This qualitative analysis
will inform development and refinement of a toolkit comprising specific strategies portable to other environments
to improve diversity, equity, and inclusion. This toolkit will then be implemented within the Rare Genomes Project
in order to enroll a cohort of 200 participants who are historically underrepresented in rare disease genomic
research, with concurrent evaluation of the following implementation outcomes: Reach, as reflected in the
demographics of study participants; Adoption, as reflected in the characteristics of referring providers; and
Implementation fidelity, as reflected in the proportion of participants who complete the study process from
enrollment to sequencing. In Aim 2, Effectiveness of genome sequencing (GS) for this cohort of 200 participants
will be evaluated, reflected in diagnostic and clinical utility, with analysis taking into account the impact of social
and structural informants of health on these outcomes. In Aim 3, patient-centered utility of GS will be assessed
both in this cohort as well as a larger, diverse cohort of rare disease genomic research participants to better
assess longitudinal, multidimensional impact (Maintenance). This study will therefore generate utility data from
a diverse population that provides real-world guidance regarding equitable applications of GS for rare disease
diagnosis. Study results will inform strategies to improve access to GS and will identify key areas of clinical
impact in order to direct policies related its clinical adoption. Successful completion of the proposed study will
thus directly inform equitable clinical implementation of genomic medicine.

Public health relevance
Project Narrative Genomic research offers a unique opportunity for rare disease diagnosis and understanding that may be transformative for people living with these complex conditions, however, access to these opportunities is inequitably distributed. With this project, we take an implementation science approach to the development and evaluation of a toolkit to improve diversity, equity, and inclusion in rare disease genomic research via a novel initiative within the Rare Genomes Project (Aim 1); evaluate the effectiveness and impact of research genome sequencing for diverse populations by identifying genetic diagnoses for historically underserved and minoritized communities (Aim 2); and explore the priorities and values of diverse populations with rare diseases undergoing research sequencing within a large consortium (Aim 3). The findings from this research will inform both research and clinical applications of genome sequencing with the ultimate goal of advancing equity for individuals and families with rare disease.